UC Davis Alzheimer's Disease Research Center

PROJECT SUMMARY/ABSTRACT - Overall
The mission of the UC Davis Alzheimer’s Disease Research Center (UCD ADRC) is to promote a highly
innovative and enriched research environment focused on understanding the heterogeneity of brain aging
among diverse populations that will ultimately lead to effective therapies to prevent or mitigate dementia.
This approach stems from the premise that emphasizing diversity enhances discovery and contributes to
translational science as well as reducing disparities in brain health and care. To accomplish this
mission, the UCD ADRC has developed innovative methods and a unique study design to recruit and retain a
highly demographically diverse clinical and autopsy cohort. All UCD ADRC participants are longitudinally
followed and deeply phenotyped with extensive clinical, blood and imaging biomarker measures as well as
developing state-of-the-art quantitative neuropathology. The UCD ADRC succeeds at these efforts through a
robust research infrastructure, state-of-the-art database management and a highly collaborative environment
consisting of seven well integrated resource cores and one research education component (REC) designed to
facilitate new research efforts and interventions, dissemination of research findings, education and training as
well as encouraging researcher development. Our approach addresses several milestones set by the National
Alzheimer’s Project Act to effectively treat Alzheimer’s disease and associated disorders (ADRD) by 2025.
These include, but are not limited to: 1) M1.L., evaluating disparities among ethnic and racial minority
populations that are at higher risk for AD to mitigate risk and improve cognitive outcomes, 2) M2.H., fully
characterizing mixed pathologies and identifying unique risk factors,3) M5-7., accelerating the development of
treatments that would prevent, halt, or reverse the course of Alzheimer’s disease (AD), 4) M9., improving early
diagnosis through discovery of novel imaging and blood biomarkers, 5) M8., developing novel dementia
prevention strategies, and 6) M13.E.,supporting caregiving through funded caregiver research. The UCD
ADRC also directly supports multiple epidemiological studies of diverse communities through use of research
methods and personnel to gain further insights into dementia risk reduction, early diagnosis, and the impact of
various neuropathologies on aging and dementia.
Our efforts reflect the evolving needs of an increasingly older and more diverse US population, which is
expected to rise to nearly 14 million by midcentury. Moreover, while AD continues to be the major pathological
cause of dementia, more recent studies—including one from the UCD ADRC—find that dementia pathology is
multifactorial and highly heterogeneous, due in part to the co-occurrence of AD and vascular disease, which
varies by ethnoracial characteristics, is emphasized as part of dementia prediction and which can be modified
by treatment even in later life. The UCD ADRC is uniquely qualified to support this research focus with a
considerable impact on future ADRD diagnosis and treatment.

Public health relevance
PROJECT NARRATIVE - Overall The vision of the UC Davis ADRC is to strive for a lifetime of brain health for all and our mission is to advance the science of healthy brain aging among diverse populations while caring for those affected by dementia. This vision and mission reflects the evolving needs of an increasingly older and more diverse US population. Moreover, while AD continues to be the major pathological cause of dementia, more recent studies find that dementia pathology is multifactorial and highly heterogeneous, due in part to the co-occurrence of AD and vascular disease, which varies by ethnoracial characteristics, is emphasized as part of dementia prediction and which can be modified by treatment even in later life.